Admin Core

ADMINISTRATIVE CORE | PROJECT SUMMARY
The objective of the CLEAR Consortium Administrative Core is to manage and coordinate
activities of all the components to ensure we meet our goal of discovering the developmental
mechanisms of trachea-esophageal birth defects. The CLEAR Consortium includes three highly
synergistic Projects and a Genomics Core, leveraging complementary expertise and resources
two leading biomedical institutions: Cincinnati Children’s Hospital Medical Center and Columbia
University Medical Center. The Admin Core Staff work closely with the Overall multi-PI team, the
staff of each component, institutional administrators, and the advisory board to execute the Admin
Core functions. The Core helps coordinate and integrate the activity of all these groups. The
Admin Core facilitates evaluation of scientific progress, is responsible for progress reports and
ensures that we all regulatory compliance. The Admin Core provides financial management
overseeing the program budget and managing the subcontracts. The Admin Core manages
communication between PIs, Performance sites, Advisory Board, NIH and external collaborators.
Finally, the Admin Core facilitates outreach to engage patients and help grow our collaborative
research network. The Admin Core is essential for the success of the Program.